VAST Center: Viromes Across Space(s) and Time

Admin Core Abstract: The Administrative Core, jointly led by Stanford and Cornell University,
will function as the organizational hub for the Viromes Across Spaces and Time (VAST) center of
the Human Virome Project (HVP) Consortium. First and foremost, the Administrative Core will
coordinate the activities of the Biospecimen Collection, Biospecimen Analysis, Data Analysis and
Submission, and Ethical, Legal, and Social Implications Cores within the VAST center. Second,
as the Administrative core is tasked with harmonizing practices across the Consortium, the Core
will collaborate with Data Analysis & Submission Cores and the HVP Coordination and Data
Collection Center (CODCC) to establish cohesive Standard Operating Practices. Finally, given
the focus on assessing the human virome, especially through the Developing Novel and
Innovative Tools initiative, the Core will guide metric development, cross-site studies, cross-
training, and the creation, benchmarking and timely dissemination of data analysis tools ensuring
data and metadata
The Core, to be headed by the VCC's contact Principal Investigator (PD/PI), Michael Snyder, will
leverage extensive experience in managing multidisciplinary teams for eukaryotic and prokaryotic
virus research. Six specific aims will drive the Administrative Core: (1) providing operational
oversight and integration, (2) fostering collaboration, communication, workshops and cross
training (3) oversee the establishment of SOPs, metrics for data generation and metadata
standards. (4) initiating Collaborative Pilot Projects, (5) broadly disseminating results, and (6)
ensuring timely milestone achievement and data deposition in appropriate repositories. Key
responsibilities will include supervising center activities, implementing plans for enhancing diverse
perspectives, and facilitating communication with the National Institutes of Health (NIH). The
Administrative Core will ensure seamless coordination within and across Virome Characterization
Centers, facilitating the submission of data adhering to agreed-upon Standard Operating
Procedures and Common Data Elements, and contributing to the overall success of the HVP. The
Steering Committee will evaluate data generation and quality, ensuring Consortium-wide
adherence to goals and milestones.